Research Project for NSRRC Renewal Year 21-25

Abstract (Applied Research)
The overall goal of this application is to continue and expand operation of the National Swine Resource and
Research Center (NSRRC). During the past funding period, the NSRRC developed a non-invasive method
of cryopreservation of embryos via ultra-fast cooling, improved methods for the development of somatic cell
nuclear transfer embryos, developed a universal sex determining assay, and incorporated a GHR knockout
in an attempt to reduce the size of domestic pigs while retaining their superior reproductive performance,
and developed state-of-the-art disease monitoring and surveillance assays. The Specific Aim of the
Research Core is to perform innovative research that will benefit the NSRRC and the biomedical research
community. Applied research projects are aimed at improving a) the cryopreservation of pig reproductive
cells, and b) the development of improved methods for the production of genetically-engineered pigs.